ER stress as the cause for dementia-associated olfactory dysfunction

Summary/Abstract
One of the great mysteries in clinical neuroscience is the differential susceptibility to neurodegenerative insults
that is exhibited by different neuronal subtypes. Understanding why Alzheimer’s disease (AD) or Amyotrophic
Lateral Sclerosis have reproducible patterns of initiation and propagation, and deciphering the exact molecular
features that determine a neuron’s tolerance to protein aggregation, will facilitate the development of new
therapies and diagnostics. Our discovery that olfactory sensory neurons (OSNs) have high baseline levels of ER
stress, determined by the sequence of the chosen olfactory receptor (OR) may provide a surprising answer to
these questions. Moreover, our demonstration that levels of ER stress instruct axon guidance specificity via the
levels of pro-apoptotic transcription factory Ddit3, may reveal novel mechanisms of AD-related olfactory
dysfunction. Thus, in this administrative supplement, we propose to build upon the striking discoveries supported
by the parent R01 grant, towards questions related to AD-linked olfactory dysfunction. Since it is well established
that anosmia constitutes a prodrome syndrome for AD, emerging as early as 10 years prior to the emergence of
cognitive symptoms, we propose that OSNs are exquisitely primed for neurodegeneration due to their high base
line of ER stress. Thus, using mouse models for AD, we will explore whether OSNs with highest levels of ER
stress and Ddit3, are the most sensitive to human mutations the amyloid precursor protein (hAPP) (Aim1).
Further, using a novel translational reporter mouse that measures ER stress levels, we will explore whether
hAPP mutants increase the levels of ER stress in mouse OSNs, pushing Ddit3 expression to toxic levels much
faster than in CNS neurons that do not have pre-existing ER stress (Aim2). Finally, we will ask whether hAPP-
induced changes in ER stress and Ddit3 induce axon guidance mistargeting, through Ddit3-mediated
dysregulation of axon guidance gene expression programs, providing molecular understanding to cellular
changes that precede amyloid plaque formation and neurodegeneration (Aim3). While the proposed experiments
will shed light to the long-standing mystery of AD-related olfactory dysfunction, they will provide novel and
general insight to the initial molecular changes that cause circuitry defects and cognitive decline in AD patients.
Thus, we propose to use the olfactory system as a model for “accelerated neurodegeneration” which will offer
novel insight to the initial, and pharmacologically reversible, cellular defects of dementia and Alzheimer’s
disease.

Public health relevance
Project Narrative Olfactory deficits constitute a prodrome syndrome of Alzheimer’s Disease (AD) and Dementia. Here, we propose to explore if high base line levels of ER stress and Perk signaling in olfactory sensory neurons render this distinct neuronal population primed for neurodegeneration. Considering that Perk signaling is pharmacologically tractable, our experiments will provide the basis for developing novel, early intervention therapeutics.